Functional and population genetic architectures of complex disease

Project Summary
Recent progress in the genetics of complex diseases, including neuropsychiatric diseases, has revealed that
the bulk of disease heritability is explained by the action of many common non-coding variants. Most of these
variants exert individually tiny effects on disease risk, but collectively they contribute most of the measurable
genetic risk for most diseases and typically account for between a third and half of twin estimates of heritability.
These observations motivate three important questions concerning the biology underlying phenotypic variation:
First, how do individual non-coding variants associated to disease impact biological function? A growing
number of studies, including those published by the Key Personnel of this renewal application, provide
statistical analyses that link genetic and epigenetic data to identify regulatory elements active in cell types that
are key to disease biology. However, the mechanism of regulatory action is understood just for a few examples
of genetic associations to disease.
Second, how do the causative variants conspire together to perturb genes, biological pathways and networks
and induce a disease phenotype? Despite the body of knowledge on genes and functional modules
accumulated by decades of experimental research, we lack understanding of specific gene programs and
networks through which the thousands of causative variants act to impact disease phenotypes.
Third, how is genetic variation associated to common neuropsychiatric diseases stably maintained in the
population given the loss of fitness associated to these disorders? Established population genetics models
applicable to rare diseases are inconsistent with recent data on common disease genetics.
We propose to develop new statistical and computational methods to generate biological insights from
genomic data and to apply these methods to genome-scale genotype-phenotype datasets.
We will design new strategies to combine functional genomic and molecular phenotype data with disease
association results to shed light on the proximal regulatory function of non-coding variants. We propose new
statistical methods to interpret genetic association data at different levels of biological organization ranging
from individual regulatory interactions to genes, pathways and networks. We will use population genetics
models to address conceptual issues of the origin of allelic architecture of common disease and, in particular,
neuropsychiatric diseases. Our collaboration has an extensive publication record and a record of producing
widely-used open-source software in the previous funding cycle. We have extensive computational and
statistical expertise, but our approach is always rooted in data. All proposed method development will be
guided by available large-scale genetics datasets and functional genomics datasets spanning over 2 million
samples.

Public health relevance
Project Narrative Recent progress in the genetics of complex diseases, including neuropsychiatric diseases, has revealed that the bulk of disease heritability is explained by the action of many common non-coding variants. We propose to develop new statistical and computational methods to infer biological function of these variants at different levels of organization. We will apply these methods to genome-scale genotype-phenotype and functional genomics datasets.